Biostatistics Facility Core

Abstract: The Biostatistics Core is an integral part of the Rochester Environmental Health Sciences Center
(EHSC). Members of the Biostatistics Core work closely with EHSC researchers to assist in the planning of
environmental health studies and analysis of environmental health data. Biostatistics Core members are active
participants in the EHSC, regularly attend monthly EHSC faculty meetings and seminars, and Dr. Thurston
(Biostatistics Core Director) is a member of the EHSC Internal Advisory Committee.
The Biostatistics Core has three primary missions:
(1) To provide EHSC investigators with the biostatistical support needed for their research;
(2) To work with EHSC investigators in developing new biostatistical methodology appropriate for increasingly
complex study designs, including those involving high-dimensional biomedical and exposure data;
(3) To provide training in biostatistical methods for EHSC members and their trainees, and offer guidance in
this area to early stage faculty in conjunction with the Career Development Program.
By focusing on and pursuing these missions, the Biostatistics Core provides support for translational
environmental health research activities. For instance, it facilitates new collaborations, fosters development of
new methodologies, and promotes longstanding collaborations. Through these efforts, the Biostatistics Core
has contributed to multiple successful grant submissions and numerous papers co-authored by Biostatistics Core
members and other EHSC faculty. Thus, the Biostatistics Core supports the overarching goals of the Rochester
Environmental Health Sciences Center (EHSC), which are to prevent disease and improve health by
advancing innovative and impactful translational environmental health research, engaging communities to
address environmental health issues, and enhancing career development of talented environmental health
investigators.